Examining Contraceptive Access and Use among Youth with Child Welfare Involvement

Project Summary
Roughly half of females with child welfare involvement report a pregnancy by age 19 , which is twice the rate of
a national sample of youth of similar age and racial/ethnic composition. To date, little is known about sexual
and reproductive health of youth with child welfare involvement beyond that they are at increased risk of
unintended pregnancy. Even less is known about the sexual and reproductive health of younger adolescents,
males, and youth who are not removed from their homes, and few data exist on contraceptive access and use.
Contraceptive access and use are critical, not only because of their implications for reducing unintended
pregnancy, but because of their effect on agency, autonomy, and lifelong socioeconomic opportunities. While
contraceptive access and use have been studied in other populations, these topics are likely distinct for youth
with child welfare involvement, given disruptions they commonly experience with systems and adults who
typically provide such education and support (i.e., families, schools), and the unique connection to another
formal system - child welfare. This project fills these gaps by using existing data from a longitudinal study of
youth with open child welfare cases during the transition to high school. The multi-wave study interviewed male
and female participants (n=245) three times across adolescence (between ages 12 to 18), and included key
variables on contraceptive access and use, sexual and reproductive health attitudes, psychosocial predictors,
and child welfare characteristics. We will first estimate the longitudinal experiences of contraceptive access
across these critical adolescent ages (Aim 1). We will also code open-ended responses to items on sources of
contraceptive access and types of contraceptives used and describe themes. After estimating trajectories of
contraceptive access and use, this project will examine modifiable factors that may buffer the risk of adversities
that youth with child welfare involvement face (Aim 2). Specifically, the project will examine whether the
following predict contraceptive access and use: a) sexual and reproductive health attitudes, b) school
attachment, c) adult social support, and d) future orientation. In Aim 3, we will assess how relationships
between the modifiable factors and contraceptive access and use may differ depending on biological sex,
race/ethnicity, and living instability. Thus, in addition to contributing knowledge around what promotes
contraceptive access and use, this project will shed light on for whom those factors predict these contraceptive
outcomes. This project will open the door for interventions and services by providing basic data on
contraceptive access and use, identifying factors that promote reproductive agency and autonomy, and
distinguishing how these factors may differ by key demographic and child welfare characteristics for a
population who encounter marginalization through a collection of intersecting identities and adverse childhood
experiences.

Public health relevance
Project Narrative This project will provide critical information on contraceptive access and use and factors that promote sexual and reproductive health among youth with child welfare involvement – a vastly understudied topic and population. The study will use secondary data from a multi-wave survey of youth, between the ages 12 and 18 with child welfare involvement, to provide basic information on contraceptive access and use across adolescence, identify modifiable factors that promote reproductive agency and autonomy, and clarify differences by demographic and child welfare characteristics – key factors for service delivery in child welfare settings.